The role of cancer in cardiovascular disease

PROJECT SUMMARY/ABSTRACT
Cancer and cardiovascular disease remain the world’s two leading killers. Historically considered
distinct entities, emerging data have identified numerous shared risk factors, and demonstrated that cancer
patients are at increased risk for cardiovascular events. However, these studies have several limitations. For
example, most of this work was unable to control for confounding related to traditional risk factors (such as
smoking) and cardiotoxic treatments (such as chemotherapy and radiation). Also, causal relationships have
not been proven, and potential mechanistic links between the diseases remain obscure. As a result, it is
unknown if cancer directly promotes cardiovascular disease, nor whether there are therapies that could
potentially treat patients with co-prevalent disease.
Given these critical barriers, the broad, long-term goal of this proposal is to precisely determine if
cancer promotes cardiovascular disease, and how it can be treated. To answer these questions, we have
assembled a diverse team of interdisciplinary investigators who are committed to rigorous and reproducible
research across the fields of population genetics, cardio-oncology, and translational medicine. We have
established an innovative program that is broad and ambitious, but has been extensively de-risked via our
access to unique transgenic animals, highly specialized human biorepositories, and emerging machine
learning-based computational methods.
Specifically, we now propose three broad lines of investigation. First, we will combine traditional
epidemiology and genetic inference approaches to carefully map causal associations and overlapping genetic
architecture between cancer and cardiovascular disease. Second, we will use advanced murine lineage-
tracing models to prove that cancer can directly promote atherogenesis (independent of shared risk factors),
while identifying underlying molecular mechanisms. Third, we will establish a novel drug discovery pipeline,
based on artificial intelligence and validated drug repurposing algorithms, which will prioritize translational
targets for the larger HLBS community to pursue. If successful, these efforts could transform the field of
cardio-oncology while supporting the stated mission of the National Institutes of Health, providing tools for the
scientific community, training the next generation of investigators, and leading to the development of new
therapies for patients with cancer and cardiovascular disease.

Public health relevance
PROJECT NARRATIVE Cancer and cardiovascular disease claim more lives than all other diseases, combined. Long considered separate entities, emerging data suggest they may interact and even directly promote one another. Defining their shared biology – and how to target it – could lead to new therapies for the world’s two leading killers.